Transcranial Direct Current Stimulation to Treat Aphasia: A Superiority Study

Abstract
Stroke is one of the leading causes of disability worldwide. The National Institute on Deafness and Other
Communication Disorders estimates that approximately 2 million people suffer from post-stroke chronic
language problems (aphasia) in the United States. The standard treatment for chronic aphasia is speech
therapy. However, the outcomes of speech therapy for chronic aphasia are often unsatisfactory, underscoring
the need for advancements in therapeutic options. Transcranial direct current stimulation (tDCS) has recently
emerged as a promising method that can have synergistic effects when applied concurrently with speech
therapy, significantly improving language outcomes. However, despite the potential transformative effect of
tDCS as an adjuvant treatment for chronic aphasia, the existing literature is composed by small sample sizes
or uncontrolled studies. From an evidence-based medicine perspective, these studies do not constitute Level 1
evidence and are not sufficient to prove superiority and justify the translation of tDCS to clinical use. Hence, a
definitive Level 1 evidence study is strongly needed and this application addresses this critical knowledge gap.
Our team has conducted the largest preliminary futility design clinical trial in tDCS and aphasia, in which we
formally demonstrated that a definitive superiority clinical trial to assess adjuvant tDCS coupled with auditory-visual speech is feasible, warranted, and not futile. Leveraging this formal and rigorous foundation, this project
will be a prospective randomized controlled clinical trial to compare auditory-visual speech therapy coupled
with adjuvant active anodal tDCS (A-tDCS) versus speech therapy coupled with sham tDCS (S-tDCS). We will
perform an adaptive Phase II/III design, in which the first portion of the study (Phase II) will determine the
optimal dose of A-tDCS (1 mA versus 2 mA) and provide a go/no-go decision for Phase III. Phase III will test
the definitive superiority of adjuvant A-tDCS at the optimal dose coupled with speech therapy versus speech
therapy alone (S-tDCS) to improve naming among individuals with chronic Broca’s aphasia. The primary
outcome measure will be the number of individuals who achieve a meaningful improvement in naming from
baseline to 4 weeks post-therapy. Improvement in aphasia severity, communication confidence, discourse, and
quality of life will be evaluated as secondary outcome measures. This project stands to be the first efficacy trial
of tDCS for aphasia, paving the way for a new clinical treatment that would directly benefit patient care. By
focusing on naming deficits in Broca’s aphasia, this trial will address a significant aspect of aphasia and lay the
groundwork for future studies exploring tDCS applications for various types and stages of aphasia, ultimately
enhancing the standard of care for millions affected by this condition.

Public health relevance
Narrative Adjuvant transcranial direct current stimulation (tDCS) is a promising strategy to improve speech therapy outcomes in individuals with aphasia after stroke. This randomized controlled clinical trial will determine whether adjuvant tDCS is superior to speech therapy alone to improve naming abilities among individuals with chronic post-stroke Broca’s aphasia.